Advancing Clinical Therapeutics Globally for HIV/AIDS and Other Infections

Abstract
Older persons with HIV (PWH) experience high rates of non-infectious, aging-related
comorbidities including frailty, diabetes (DM), and cardiovascular disease (CVD) compared to the
general population. Geroscience approaches focus on therapeutically targeting fundamental
aging processes to delay onset of or alleviate aging-related comorbidities. Cellular senescence is
a fundamental aging process for which targeted compounds have recently been identified. This
process is characterized by stable growth arrest and chronic inflammation, measurable markers
of which are known as the Senescence-Associated Secretory Phenotype (SASP). Senescent cell
burden and SASP-related factors have been associated with frailty, diabetes, and cardiovascular
disease in persons without HIV. Compared to tissue markers of cellular senescence, soluble
SASP biomarkers are easier to obtain, allowing their application more diverse clinical settings
However, associations between soluble SASP biomarkers and frailty, DM, and CVD have not
been well-characterized among PWH. The proposed study will examine the longitudinal
associations between levels of soluble SASP biomarkers and frailty, CM, and CVD in older PWH
in the AIDS Clinical Trial Group (ACTG) A5322/ HIV Infection, Aging, and Immune Function Long-
term Observational Study (HAILO). This study will extend the work of our currently funded cross-
sectional analysis of SASP biomarkers and frailty, DM, and CVD among HAILO participants and
be the first to characterize the longitudinal associations between SASP biomarkers and these
conditions of interest among PWH. The findings from this study will provide pilot data for potential
biomarkers to be targeted in future interventional trials using senotherapeutic agents to prevent
or alleviate frailty, DM, or CVD among older PWH.

Public health relevance
Project Narrative There are four ACTG protocols in late state of development and one recently opened that will be conducted entirely at African sites (A5416 and A5417) or will include South American sites (A5374, A5388 and A5389). These will evaluate broadly neutralizing antibodies alone or in combination with other immune therapeutic interventions in different study populations, including PWH at primary infection, started on ART during primary infection and chronically suppressed on ART. These are highly complex studies that involve multiple investigational products and include a period of analytical treatment interruption with close monitoring of participants. The success of these studies depends on the engagement and training of multiple stakeholders that include regulators and ethics committee boards, site investigators and staff, community members and advocates, potential participants and their partners and providers. It is therefore imperative for our network to support our existing sites during the expansion of our Cure research agenda. Such efforts include (1) training staff on the need for Cure interventions and scientific rationale underlying current investigational strategies and on (2) the rationale for the use of ATIs in the evaluation of such interventions, as well as the risks and mitigation plans around ATIs; (3) engagement with regulators, community members, providers and participant families and partners; (4) providing appropriate infrastructure for the conduct of the studies and associated procedures, including appropriate sample collection, processing and storage.